AFRICAN AMERICAN STUDY OF KIDNEY DISEASE AND HYPERTENSION

This study aims to determine whether usual blood pressure control is different from low blood pressure control in slowing the progression of hypertension-induced renal disease in African-Americans. The second objective is to determine whether a calcium channel blocker, an ACE inhibitor or a beta blocker are different in their effects to slow progression of hypertension-induced renal disease in African-Americans.